Prostate cancer risk stratification via computational 3D pathology

Summary. Prostate cancer (PCa) treatment management is currently heavily reliant upon slide-based
histology of prostate biopsies and surgical specimens (prostatectomies). In particular, Gleason grading of
histology sections provides a basis for stratifying patients for clinical management, and can result in dramatically
different treatment paths. However, prognostication via Gleason grading suffers from several shortcomings,
including subjective visual interpretation of complex 3D glandular morphologies based on 2D images, and
analysis of a limited amount of tissue (~1% of the biopsy). These shortcomings contribute to poor inter-observer
concordance amongst pathologists and poor stratification of patients with indolent vs. lethal disease. For the
clinical management of PCa, two major challenges faced by urologists and oncologists, respectively, are: (1)
correctly identifying men with low-risk PCa for active surveillance and (2) identifying men who are likely to have
disease recurrence and metastasis after curative therapy (surgery or radiation), and hence would benefit from
adjuvant therapy. With our open-top light-sheet (OTLS) microscope technologies, our team at the University of
Washington (Liu group) has demonstrated the technical feasibility of achieving high-throughput slide-free 3D
histology of biopsy and surgical specimens in a nondestructive and reversible manner that does not interfere
with current histology methods. Potential benefits over traditional pathology include: (1) comprehensive imaging
of specimens (biopsies and surgical bread loafs) rather than sparse sampling of thin sections on glass slides;
(2) volumetric imaging of 3D structures that are prognostic; and (3) non-destructive imaging, which allows
valuable biopsy specimens to be used for downstream assays. Our team at Case Western Reserve University
(Madabhushi group) has also developed computational pathology classifiers, based on intuitive and interpretable
“hand-crafted features,” for characterization of PCa aggressiveness based on 2D whole-slide imaging (WSI). In
this R01 project, we seek to combine nondestructive 3D pathology with 3D computational pathology approaches
to develop a novel prognostic assay, Prostate cancer Image Risk Score via 3D pathology (ProsIRiS3D), for
discriminating between indolent and aggressive PCa. In Aim 1, we will develop the core technologies (hardware
and software) for ProsIRiS3D. In particular, the goal of Aim 1a is to develop a “4th-generation” OTLS microscopy
system capable of achieving sub-nuclear-resolution to explore the added prognostic benefit provided by such
high-resolution features. In Aim 1b, computational imaging tools will be developed for extraction of novel 3D
quantitative histomorphometric features for PCa prognostication. Our clinical validation studies will show that
ProsIRiS3D is superior to analogous 2D approaches for urologists (Aim 2), to determine which newly biopsied
patients should be placed on active surveillance vs. curative therapy, as well as for oncologists (Aim 3), to
determine which prostatectomy patients have aggressive disease that may warrant adjuvant therapies.

Public health relevance
Relevance to public health This project will develop a nondestructive assay for prostate cancer prognostication based on quantitative histomorphometric analysis of 3D pathology datasets of prostate specimens (biopsies and surgical excisions). This project will demonstrate that computational 3D pathology is superior to computational 2D pathology (including existing clinical nomograms) for distinguishing between aggressive and indolent prostate cancers, and therefore has value for guiding treatment decisions by urologists and oncologists.